Activation of the Secretin Receptor as a Strategy for the Treatment of Heart Failure

PROJECT SUMMARY/ABSTRACT
Heart failure is a major cause of morbidity and mortality in the population, with rising incidence of
cardiovascular disease contributed to by epidemic increases in obesity and associated type 2 diabetes
mellitus. Although existing drugs are effective in acutely correcting decompensated heart failure, this continues
to be associated with unacceptable rates of rehospitalization and mortality. A drug combination adding
neprilysin inhibition to the previous standard-of-care for heart failure, angiotensin receptor blockade, was
recently approved by the FDA based on its ability to extend the life of patients with reduced cardiac output.
However, the broad action of the peptidase inhibitor in this combination could theoretically be improved,
thereby reducing possible side effects and increasing therapeutic effectiveness. The specific enzyme substrate
responsible for the beneficial effects of this drug is not yet clear. While it has been assumed to be natriuretic
peptides, other peptides are also cleaved by neprolysin, many of which have potential offsetting and/or side
effects. Another prominent potentially beneficial substrate of this protease is secretin, a peptide hormone with
useful effects on cardiac contractility and ejection fraction, coronary perfusion, peripheral vascular resistance,
post-cibal satiety, and glucose-sensitive incretin action. Prior to work supported by this grant in its previous
funding cycle, there were no small molecules known to mimic or enhance secretin activity at its receptor. In
that work, we screened nearly 400,000 compounds and identified several structural classes of compounds that
demonstrate robust and reproducible activation of secretin receptor signaling in vitro in model cell systems. As
a continuation of those encouraging data, we now propose to utilize medicinal chemical approaches to
optimize the scaffolds identified in the previous work. These include compounds with the ability to act as
positive allosteric modulators of secretin action, as well as those having intrinsic agonist activity. We will utilize
cycles of systematic chemical modification and rational enhancement with in vitro pharmacologic
characterization to improve their pharmacological and ADME/T properties (Aims 1 and 2). The best candidates
in each structural series will be studied using in vivo animal models to evaluate their oral bioavailability and
efficacy, as well as an in vivo rat model of ischemic heart failure (Aim 3). Our approach will validate this
receptor as an attractive target for therapeutic intervention in heart failure and provide first-in-class small
molecule compounds that we hope to take into clinical trials in the future.

Public health relevance
PROJECT NARRATIVE This project is designed to utilize medicinal chemistry to optimize hits from our previous high throughput screening of small molecules with activity to mimic or enhance secretin activity at its receptor, and to demonstrate activity in a rat model of heart failure. We hope to identify drug candidates with ability to safely and effectively improve clinical outcome for patients with heart failure by targeting this receptor, with potential to enhance the ability of the heart to contract more effectively and to act on blood vessels to bring more blood to the heart and improve peripheral circulation, as well as improving appetite control and glucose metabolism.